Metabotropic glutamate receptor signaling under physiological and pathophysiological conditions

PROJECT SUMMARY
Group III metabotropic glutamate receptors (mGlu4/ 7/ 8) have emerged as targets for modulating glutamatergic
synaptic transmission and plasticity in the brain areas implicated in schizophrenia and for regulating various
symptoms associated with schizophrenia. Further, emerging literature suggests that polymorphisms in genes
encoding for mGlu4 and mGlu7 are associated with increased risk of a schizophrenia diagnosis and may predict
improvement in symptoms after treatment with antipsychotics. However, the circuit-specific mechanisms by
which activation of these receptors can affect schizophrenia-like physiological and behavioral deficits in rodent
models relevant to schizophrenia are not clear. We present extensive data that a novel agonist of mGlu4/7
receptors, LSP2-9166, decreases excitatory neurotransmission at synapses from thalamic (TH), but not
basolateral amygdala (BLA), afferents to dopamine receptor 1 expressing medium spiny neurons (D1-MSNs) in
the nucleus accumbens (NAc). LSP2-9166 also corrects phencyclidine- (PCP, which causes pathophysiological
changes and behavioral disturbances relevant to schizophrenia in rodents)-induced increases in glutamatergic
neurotransmission at TH-D1-MSN synapses in the NAc. These novel findings provide mechanistic insights into
gene polymorphism studies showing associations between mutations in gene encoding for mGlu4/7 receptors and
risk for developing schizophrenia and suggest that agents modulating mGlu4/7 signaling may provide
symptomatic relief in schizophrenia patients. We will now use selective negative allosteric modulators of mGlu4
and mGlu7, as well as optogenetic approaches, to modulate the activity of specific neuronal populations to test
the proposed aims. In specific aim 1, we will use LSP2-9166, either alone or in the presence of selective
pharmacological tools to test the hypothesis that LSP2-9166 acts at mGlu4/7 and selectively reduces
glutamatergic neurotransmission from thalamic afferents in the NAc. In specific aims 2 and 3, we will directly test
the hypothesis that activation of mGlu4/7 will normalize abnormally high glutamatergic signaling through thalamic
afferents in the NAc and rescue sociability deficits in mice treated with PCP during juvenile development. These
results will provide important information about the function of mGlu3 in brain circuits relevant to schizophrenia
and will guide discovery efforts to develop highly selective modulators targeting either mGlu4 or mGlu7 receptors
as novel therapeutics for treating behavioral deficits in schizophrenia.

Public health relevance
PROJECT NARRATIVE Gene polymorphism studies involving schizophrenia patients and preclinical studies suggest that drugs that selectively activate metabotropic glutamate receptor 4 and 7, mGlu4/7, may provide a novel approach to the treatment of this debilitating brain disorder. Our preliminary evidence indicates that a novel agonist of mGlu4/7 receptors modulates glutamatergic neurotransmission at synapses from thalamic afferents to dopamine receptor 1-expressing medium spiny neurons in the nucleus accumbens, a brain area involved in the regulation of reward and motivation during physiological and disease conditions. Employing a combination of highly selective pharmacological compounds, state-of-the-art ex vivo electrophysiology tools, and optogenetic and behavioral approaches, we will test the hypothesis that activation of mGlu4/7 will correcting schizophrenia-like physiological and behavioral deficits in mice administered with phencyclidine during juvenile development.